A Person-Centered Environmental and Sensory Intervention for Nursing Home Residents with Dementia who Exhibit Persistent Vocalizations

Project Summary/Abstract
This K23 application describes the background and experience of the applicant, Justine S. Sefcik, PhD, RN. It
details her plan to acquire the training necessary to achieve her long-term goal to be an independent
investigator developing and testing adaptive, non-pharmacological environmental and sensory interventions
involving technology to reduce persistent vocalizations (PVs), a common behavioral and psychological
symptom of dementia. PVs refer to vocal sounds or inappropriate use of words which are repetitive, persistent,
and are upsetting to persons exhibiting them or to others in the same environment. There are known profound
negative effects to persons residing in nursing homes (NH) living with dementia and exhibiting PVs, including
physical exhaustion, reduced quality of life, and some NH staff using inappropriate interventions (e.g.,
administering chemical restraints). Unmet needs, such as a need for sensory stimulation and engagement in
meaningful activities, may be a contributor to PVs, according to the Need-driven Dementia-compromised
Behavior model. Innovative non-pharmacological interventions are urgently needed to reduce PVs. This
proposal includes a new application of a nature-based intervention that includes the projection of person-
centered nature images with the playing of associated nature sounds for NH residents with dementia and PVs.
The intervention, Environmental And Sensory Experience (EASE), was designed based on evidence that
engaging with nature elements is a meaningful activity, has a calming effect, and contributes to better moods in
people with dementia. Participants (n = 32) will wear a wrist sensor collecting heart rate and electrodermal
activity (measures of stress) and be observed 30 minutes prior to-, 30 minutes during-, and 30 minutes
immediately after the EASE. The research aims are to: 1) Examine the feasibility and preliminary efficacy of
EASE to reduce PVs among NH residents; 2) Evaluate the staff perception of the acceptability of EASE within
48 hours post-intervention, and 3) Examine the mechanism of action of EASE. In the short term, this proposal
will allow Dr. Sefcik to: 1) build on her dissertation focused on NH residents with dementia and PVs; 2) gain
new skills with behavioral intervention research; and 3) obtain NIH Phase 1 clinical trial data to determine
preliminary efficacy of the EASE. The specific training objectives within this application include: 1) Develop
skills in designing and implementing tailored, person-centered environmental and sensory behavioral
interventions for clinical trials; 2) Acquire skills in biobehavioral measurement, analysis, and dissemination of
clinical trial research; and 3) Examine the role of technology for environmental and sensory intervention
approaches and measurement for clinical trial research. The University of Pennsylvania is a research-intensive
environment with rich resources that will facilitate Dr. Sefcik’s development. This proposal aligns with NINR’s
strategic mission to build evidence toward successful symptom management and will be foundational for a R-
level submission that will build on these study findings and evaluate the effectiveness of the EASE.

Public health relevance
Project Narrative Persistent vocalizations, a common behavioral and psychological symptom of dementia, exhibited by nursing home residents with dementia represents a significant public health burden in terms of negative effects experienced by the person exhibiting this behavior and the distress experienced by staff, other residents, and family members witnessing the behavior. This research is designed to test a behavioral intervention that incorporates the use of projected nature images and the playing of associated nature sounds as a cost- effective solution to potentially reduce persistent vocalizations. The findings of this research will inform a future, larger scale clinical trial to evaluate the effectiveness of this theory based, low-cost, person-centered Environmental And Sensory Experience (EASE) intervention which has the potential to increase quality of life for residents with dementia and PVs and promote a more therapeutic nursing home environment.